Neural and motivational mechanisms of age-related change in emotion regulation

PROJECT SUMMARY
In the progression from middle to older-age, healthy adults typically experience improvements in their emotional
functioning, such as increases in positive emotion and greater expertise in managing emotions. However, not
everyone shows these age-related improvements, and the mechanisms that give rise to emotional functioning
changes across adulthood are still poorly understood. The primary goal of this project is to examine the critical
factors that promote positive emotional development in normative aging, and to test whether depression history
might moderate this process as a key trait individual difference marker. To this end, we test our proposed Value-
Based Cognitive Control Model of Emotion Regulation in ADulthood (VBCC-MERiAD). The VBCC-MERiAD
framework suggests a novel insight: that interactions between reward motivation and cognitive control play a
central role in understanding both the normative trajectory of emotional functioning in older adults, and
conversely, why and how individuals with depression histories may get “off track”. We focus on effectively
upregulating positive emotion, given that older adults prioritize positive emotion goals, and because depression
is characterized by blunted reward processing. Our primary hypothesis is that positive emotion regulation (ER)
abilities will rely upon the integrity of fronto-striatal circuitry (i.e., activity and connectivity between the lateral
prefrontal cortex and nucleus accumbens / ventral striatum). Engagement of this circuit is predicted to reflect the
utilization of reward motivation as a means of engaging cognitive control (i.e., to update and maintain ER goals).
Across three Specific Aims, we propose to characterize the mechanisms of ER in middle-aged and older adults
(35-74), focusing on neural and behavioral indicators of motivation and cognitive control that predict daily
emotional functioning, and potential dysregulation in individuals with depression history. To achieve these aims,
we will employ a multi-method design involving functional neuroimaging measures, laboratory behavioral
assessments, and experience sampling methods. The sample (N=220) will include an ethnically/racially diverse
set of adults (66% women) of ages 35-74, equally subdivided into two groups: healthy controls and people with
depression histories. A state-of-the art neuroimaging protocol will assess brain activity associated with different
ER strategies, and test for linkages with reward-motivated cognitive control. The comprehensive laboratory
assessments will include diagnostic interviewing, self-report measures, cognitive functioning batteries, and a
standardized ER task with measures of autonomic reactivity and behavioral coding of emotion. The experience
sampling protocol will provide a naturalistic, ecologically valid assessment of participants’ emotional
experiences, goals and regulatory strategies. The proposed research will dramatically extend our understanding
of both normative and dysfunctional age-related change in emotional function, by identifying mechanisms that
promote positive ER in late adulthood. In so doing, we will lay the foundation for new interventions to improve
quality of life for healthy older adults and preventative therapeutic targets for individuals with depression history.

Public health relevance
PROJECT NARRATIVE Healthy aging is associated with a striking paradox: As adults age, they typically have better control over their emotions while also simultaneously experiencing decline in cognitive functions and brain systems that have been associated with emotion regulation. This study will investigate the brain basis of emotion regulation in middle- and older-age adults, and how a history of depression might impact the typical pattern of age-related improvement in emotional control. Ultimately, the proposed research will help to improve quality of life for healthy older adults, while also providing treatment targets to prevent recurrence of depression for those with a depression history.